Molecular mechanisms of transthyretin amyloidosis

Many debilitating human diseases are associated with the extracellular misfolding and aggregation
of globular proteins to form fibrillar deposits that are rich in -structure. There is considerable
evidence that the process is initiated by local unfolding of the native structure to form aggregation-
prone amyloidogenic intermediates. Aggregation then proceeds via nucleation-growth or downhill
polymerization mechanisms. Transthyretin amyloidosis is associated with numerous
neurodegenerative diseases and cardiomyopathies. Misfolding and aggregation of transthyretin
leads to fibrous deposits in the peripheral nerves and heart. Deposition of wild type protein is age
related, whereas the familial diseases associated with genetic mutations that destabilize the
quaternary and/or tertiary structure are early onset. Aggregation is extremely slow at physiological
pH and temperature and all in vitro studies of the aggregation pathway to date have used non-
physiological conditions (acidic pH) to accelerate the process. Recent clinical studies suggest a
causal relationship between arterial and aortic valve stenosis, which results in turbulent blood flow,
and transthyretin cardiac amyloidosis. The proposed research will provide novel insights into the
fundamental molecular mechanisms by which shear forces associated with fluid flow promote
aggregation of wild type transthyretin and pathogenic variants under physiological conditions. A
comprehensive suite of biophysical tools (light scattering, fluorescence, NMR, and optical and
electron microscopy) will be used to elucidate the mechanistic pathway by which transthyretin
aggregates under laminar and turbulent shear stress. NMR will be used to map the kinetic
aggregation landscape of wild type and pathogenic variant transthyretin, characterize and quantify
the population of intermediates that accumulate on the aggregation pathway, and elucidate the
mechanism by which shear forces promote proteolysis and fibril formation. Morphological changes
during aggregation and fibril growth will be monitored by optical and electron microscopy. Real-time
NMR experiments using a novel rheological NMR device will be used to probe shear-induced
changes in the conformation and dynamics of wild type and pathogenic variant TTR that initiate
misfolding and aggregation. This research will advance our understanding of the fundamental
molecular events that initiate transthyretin aggregation at physiological pH and temperature and
promote entry into and progression down the aggregation cascade that leads to amyloid formation
and human disease.

Public health relevance
The proposed research will address the fundamental molecular mechanisms by which transthyretin misfolds under physiological conditions and aggregates to cause human disease. Transthyretin amyloidosis plays a causative role in numerous age-related and familial neurodegenerative diseases and cardiomyopathies. This research will provide novel insights into the fundamental molecular mechanisms by which mechanical stresses associated with the flow of blood and cerebrospinal fluid, which are amplified by the onset of turbulent flow due to aging and disease, perturb the structure and dynamics of transthyretin and initiate the aggregation cascade.